Parasitology and Vector Biology Training Program

7. Project Summary/Abstract
Parasitic diseases caused by protozoans, helminths, and arthropod-vectored infectious diseases continue
to plague much of the developing world. Even in industrialized nations, poorer communities are deeply
affected by parasitology and arthropod-vectored infectious diseases, especially in the southern Gulf Coast
region of the United States. What is needed to combat these devastating infections is a new generation of
researchers focused on parasitology and arthropod-vectored infectious diseases; however, there are only a
few NIH T32s focused on parasitology and vector-borne infectious diseases. One of these T32s is the
Parasitology and Vector Biology (PVB) Training Program at the University of Wisconsin-Madison. The PVB
training program aims to attract and train the next generation of parasitology/vector biology investigators by
providing opportunities to study significant, cutting-edge research problems associated with these important
neglected tropical diseases. This goal will be accomplished by trainees acquiring a solid foundation of
advanced knowledge through coursework and seminars, and then combining this knowledge with the latest
technologies available in the laboratories of our 16 faculty trainers. Funding for this renewal is requested for
5 years to support 4 predoctoral trainees per year. After matriculating into one of three main graduate
degree programs and successfully completing the first year of graduate school, PVB trainees will be
appointed for 2 years. In addition to meeting their degree program requirements, trainees are required to
complete courses in research ethics, rigor and reproducibility, and general parasitology, as well as complete
an individual development plan, update it yearly, and present their research annually in the PVB seminar
series. In an effort to increase the diversity of graduate students seeking advanced degrees in parasitology
and vector biology, plans are described to identify and recruit under-represented minority (URM) students.
This plan has been successfully active during the last two cycles of the PVB and has increased our number
of URMs trainees in the program. Providing cutting-edge and well-rounded training in molecular
parasitology and arthropod-vectored infectious diseases for predoctoral trainees has been and will continue
to be our mission. Given the worldwide need to combat these infections, we must train the next generation
to think broadly about parasite and arthropod-vectored diseases so that novel solutions to these devastating
problems they cause can be found.

Public health relevance
8. Project Narrative Diseases caused by protozoan and helminth parasites and arthropod-vectored infectious diseases continue to affect millions of people in resource-poor developing countries. The goal of the Parasitology and Vector Biology training program is to recruit and train the next generation of investigators whose focus is on understanding the basic mechanisms regulating host-parasite interactions as well as animal and human parasite transmission. These future parasitology and vector biology research leaders will contribute to global efforts to control these devastating diseases.